IUB C3A Administrative Core

The Administrative Core will provide oversight and a cohesive framework to maximize the efficiency and
impact of the IU Bloomington Center for Cannabis, Cannabinoids and Addiction (IUB C3A). It will be led
by Dr. Ken Mackie, a Gill Chair and Distinguished Professor in the Department of Psychological and Brain
Sciences at IU Bloomington. Dr. Mackie has more than 30 years of experience in drug abuse research at the
University of Washington and Indiana University Bloomington (IUB). During this time his research has been
continuously funded by NIDA, NINDS and/or NCCIH, including serving as a project PI for two different NIDA
P01’s. He has served in several demanding administrative research positions at IUB, including directing the
Gill Center for nine years where he oversaw its substantial growth by recruiting four new endowed chairs to
IUB and the Gill Center. He and the other four C3A PIs have had longstanding and productive collaborations
(and Dr. Mackie played a major role in their recruitments to IUB) and has published more than 60 papers with
them over the last twenty years. All these factors suggest that the Administrative Core will function efficiently
to achieve the overall goals of the C3A.
The Administrative Core is efficiently structured to accomplish the following specific aims:
1. Provide the administrative framework to ensure that the goals of the IUB C3A are met. In addition to
Dr. Mackie, this framework includes the core PIs and key technical staff (together forming the Steering
Committee, responsible for governance and day-to-day Center operations), an internal advisory board (IAB),
and an external advisory board (EAB). The advisory boards will provide strategic advice to the PIs, help
review pilot projects, evaluate Center impact, and offer suggestions for improvement.
2. Facilitate communications within the Center, with the greater Drug Abuse community, and the
public. This will be done by organizing monthly center meetings, hosting external speakers, and managing
the Center’s internet and social media presence. An important activity of the Administrative Core will be
archiving and facilitating access to the data sets and other resources generated by the Center.
3. Organize the courses offered by the Centers. The Administrative Core will be responsible for the
administration of the two courses that will be offered by the Center. This will be done by publicizing the
courses, fielding questions about them and their content, handling registrations, providing advice on travel and
lodging, disbursing scholarships for appropriate students, liaising with IUB on integration of the summer BLMC
course with existing IUB URM-oriented summer courses, and collecting post-course evaluations and follow up.
4. Provide administrative support to improve the Core’s efficiency. Essential administrative activities that
are more efficient when centralized (e.g., ordering, fiscal management, compliance, animal management, etc.)
will be provided by the Administrative Core.